Chemical Biology Approaches to Studying Collagen IV Stability

PROJECT SUMMARY/ABSTRACT
Collagens are essential components of the extra-cellular matrix and basement membranes, where they serve to
maintain tissue integrity, facilitate cell migration, and organize signaling molecules. To achieve these activities,
mature collagens are secreted from cells as stable trimers. Each collagen protomer is composed of three
domains: a C-terminal, non-collagenous (NC1) domain, a collagen domain and an N-terminal domain (NTD).
Newly synthesized collagen proteins undergo a unique “C-to-N” folding pathway in the endoplasmic reticulum
(ER), in which individual, C-terminal NC1 domains first assemble into trimers prior to collagen triple helix
formation. Collagens are also heavily modified by post-translational modifications (PTMs) prior to secretion of
mature collagen trimers to the extracellular space.
Collagen-associated disorders (CADs), such as Osteogenesis Imperfecta, Ehlers-Danlos syndrome (EDS) and
Alport’s syndrome, are relatively common (1:5,000 to 1:10,000) genetic diseases that most commonly arise from
mutations in collagen genes. Because of the key roles played by collagens in ocular tissues, vision loss is a
common feature of CADs. For example, ocular dysgenesis is a feature of Gould Syndrome, a rare genetic
disorder associated with mutations in type IV collagen a1 (COL4A1) and type IV collagen a2 (COL4A2). We
propose that stabilizing NC1 interactions with genetic (e.g., gene therapy) or chemical (e.g., molecular glues)
approaches is a potential, new way to treat Gould Syndrome. Specifically, we envision that stabilization of
COL4A1-COL4A2 contacts will partially overcome the impact of missense or nonsense mutations by driving
assembly of type IV collagen [a1a2a2(IV)] heterotrimers. To explore this idea, we used computational protein
design to create a “stabilizer” variant, COL4A2S150W, in which residue packing at the COL4A2-COL4A1 interface
is optimized. Indeed, we found that expression of COL4A2S150W enhanced biogenesis of collagen [a1a2a2(IV)]
by 7-fold in a quantitative, cell-based model. Now, we are poised to (Specific Aim 1) screen Gould Syndrome-
associated mutations to reveal which ones can be partially corrected in cell-based and biochemical models.
Then, we will (Specific Aim 2) conduct high throughput chemical screens, which leverage our innovative, cell-
based assays and “stabilizer” COL4A2S150W tool, to identify drug-like molecules that promote collagen
[a1a2a2(IV)] biogenesis. Together, we expect these studies to reveal the relationship between NC1 affinity and
collagen secretion in models of Gould Syndrome. We also hope to produce starting points for new Gould
Syndrome treatments and provide a framework for potentially treating other CADs.

Public health relevance
PROJECT NARRATIVE Mutations in collagens give rise to a large family of diseases, termed collagen associate disorders (CADs). These diseases often have severe symptoms, including skeletal and cartilage abnormalities, skin fragility, hearing/vision loss and muscle weakness. Here, we will explore whether stabilizing collagen is a new way to potentially treat CADs.